University of Wisconsin Voice Research Training Program

PROJECT SUMMARY/ABSTRACT
Since 2009, the long-term goal of the UW Voice Research Training Program has been to foster the
development of translational research skills in future leaders in the field of voice science. We provide promising
predoctoral and postdoctoral fellows with highly interactive and multi-disciplinary training experiences that are
unfettered by conventional departmental barriers, and actively facilitate their development as independent
scientists. Fellows partake in comprehensive laboratory, translational, and clinical research experiences, as
well as exposure to curricula in clinical trials, hypothesis-based research, management, ethics, and data
analysis. Further, the training program offers medical students a short-term summer research opportunity to
encourage future clinicians to become physician-scientists. The program capitalizes on the abundant university
resources, including the UW CTSA Institute for Clinical and Translational Research, thereby creating an
outstanding voice training program that is not matched elsewhere. Our pool of experienced, extramurally
funded trainers, from a variety of disciplines including otolaryngology-head and neck surgery, medicine, human
oncology, biomedical and chemical engineering, bacteriology, and communication sciences and disorders
incorporates effective assessment processes, a plan to promote diversity by recruiting and retaining both
women and minorities, and a solid plan for training in the responsible and ethical conduct of research. This
renewal application, based on our immense success over the last 14 years, requests an additional five years of
funding for 5 predoctoral, 3 postdoctoral, and 2 short-term fellows each year. An important metric of success of
our past performance to date is that 31 predoctoral and postdoctoral fellows have completed the program (6
fellows are currently appointed) and have progressed onto competitive postdoctoral positions and academic,
industry, or government research careers. We have had 24 short-term medical students with 2 enrolled for
summer 2023. Other indicators of success of the program include 17 NIH F31 and F32 fellowship awards to
our trainees, other NIH funding (Loan Repayment, K23, K99, R21 and R01s) received to past trainees, in
addition to countless other awards, grant funding, and scholarships. For each fellow, the UW Voice Research
Training Program has a proven track record of creating a dynamic research experience with an outstanding
collaborative research team. Renewal of this training program will ensure the continued excellence and
engagement of the next generation of voice scientists.

Public health relevance
Project Narrative Voice disorders affect approximately 7.5 million Americans. However, there are not enough individuals with the expertise and training to perform high-quality basic, translational, and clinical research that will result in successful treatments for these disorders. The University of Wisconsin-Madison Voice Research Training Program is training graduate students as well as individuals with PhDs and MDs to lead successful academic careers with a focus on research in voice.